Orchestration of the antibody response by PI3K-gamma

Project Summary
Over the last decade, novel inborn errors of immunity caused by mutations in phosphoinositide 3-kinase
(PI3K) genes have illuminated new biology with significant relevance for basic and translational immunology. We
recently reported deficiency in the PI3Kg kinase that has distinct functions relative to the related PI3Kd complex
that is considered the major PI3K in lymphocytes. A key and unexpected finding from human PI3Kg deficiency
was defective antibody responses, resulting in humoral immune deficits and recurrent sinopulmonary infections
requiring immunoglobulin replacement therapy. These novel insights launched us toward basic science
hypotheses leveraging the power of mouse models to definitively establish an essential role for PI3Kg in the IgG
antibody response and generation of IgG antibody-secreting cells (ASCs). Here, we will pursue new mechanistic
questions addressing impactful knowledge gaps on the molecular basis of our discovery and its therapeutic
implications. We propose three aims to address our hypothesis that B cells integrate signals transduced via
PI3Kg to support cell biologic changes required for differentiation into IgG ASCs. In Aim 1, we will define
downstream effects of PI3Kg in orchestrating cell biologic processes in B cells to promote IgG ASC differentiation.
In Aim 2, we will dissect molecular determinants upstream of PI3Kg during differentiation of ASCs from naïve or
memory B cells. Finally, in Aim 3, we will test the prediction that modulation of PI3Kg activity will modulate
pathological ASC responses. Together, this proposal will elucidate new and targetable pathways that regulate
the antibody response in humans and mice, with important implications for responses to infection and vaccination
and for therapeutic intervention in antibody-driven disease.

Public health relevance
Project Narrative Monogenic human diseases offer new biological insights from human ‘experiments of nature’ that pinpoint physiologically relevant immune genes and pathways critical for human health. This proposal builds from our prior discovery of human PI3Kg deficiency causing an immunodeficiency with antibody defects to dissect fundamental biology of the antibody response using a variety of powerful mouse modeling tools and mechanistic approaches leveraging both mouse cells and cells from healthy human subjects and patients. Together, these aims will test our innovative hypotheses and open new doors for both fundamental advances in our understanding of antibody secreting cell (ASC) fate choice and therapeutic targeting of PI3Kg for modulation of antibody responses.